MULTICENTER STUDY OF ADENOCARCINOMA OF THE UTERINE CERVIX

The main goal of this study is to investigate risk factors and to determine the similarities and differences in etiological profiles between this rare histological type of cervical cancer and those of squamous orgin. Protocol has been terminated, and its data being analyzed.